Motor feedback control of layer six circuits

PROJECT SUMMARY
The neocortex is essential for movement, sensation, and higher cognitive functions. A key organization feature
of the cortex is that it comprises several distinct areas that are interconnected by long-range corticocortical
pathways. These direct corticocortical connections are generally thought to mediate cognitive processes like
attention, prediction, and awareness. Dysfunction in corticocortical connectivity has been associated with certain
neurological disorders like autism, epilepsy, and schizophrenia. Long-range corticocortical connections link
hierarchically organized cortical areas. For example, lower-order cortical areas such as sensory cortices
communicate sensory receptive field information to higher-order areas via feedforward pathways (FF). In
contrast, higher-order cortical areas send feedback projections (FB) to lower-order areas and are thought to
modulate the responsiveness of their target cells. Recent work suggests that local GABAergic interneurons play
a critical role in cortical feedback modulation. Although much is known about the FB recruitment of inhibitory
circuits in superficial layers (layer 2/3), the underlying inhibitory circuits involved in FB modulation in deep layers
(layer 5/6) are unknown. Indeed, previous anatomical and physiological studies strongly suggest that IN
populations are distinct between superficial and deep layers of the cortex, suggesting that different inhibitory
circuits could be involved in cortical feedback circuits. This proposal will investigate the inhibitory networks
mediated motor integration in layer 6 of the mouse somatosensory cortex. There are three specific aims in this
proposal: 1) Characterize layer 6 inhibitory cell types recruited by vM1 input; 2) Determine what different
subtypes of L6 excitatory cells are activated by vM1 input; 3) Determine the functions of vM1 evoked FFI to
excitatory cells in L6. To address these aims, I will use an array of in vitro electrophysiological techniques
combined with various optogenetics approaches, transgenic mouse lines, and histological methods to identify
the inhibitory circuits mediating motor integration in L6 of the somatosensory cortex. Ultimately, these findings
will advance our fundamental understanding of corticocortical connectivity and how the motor cortex influences
processing in the sensory cortex. Such information will be necessary for understanding certain neuropsychiatric
disorders involving corticocortical communication.

Public health relevance
PROJECT NARRATIVE This project focuses on understanding the physiology of neural circuits in the neocortex, an area essential for normal movement, sensation, and higher-order functions like cognition and perception. Dysfunctional neocortical networks underlie many neurological disorders, such as autism, epilepsy, and schizophrenia. This work will advance our knowledge of normal neocortical functioning, leading to improved treatments for patients with certain neurological disorders.